Methods Core

Methods Core Abstract
The Methods Core for the STAND ALACRITY Center will serve several functions. It will support all research
projects, including the Signature Project and Project 3 focused on optimizing effectiveness, Projects 1 and 2
focused on barriers (i.e., uptake and engagement) and other pilot projects focused on optimizing implementation
and adapting STAND to meet the needs of a diverse student population. The Methods Core will support these
projects by providing technical, methodological, and statistical support through an interdisciplinary team of
investigators with expertise in clinical science (including college mental health), data science, digital mental
health science, health disparities/cultural competency, and implementation science/public health. These
investigators will participate in working groups in each of these areas, with clear goals and areas of focus to
support research that serves the Overall Aims of the Center. The Methods Core will also work closely with the
Administrative Core to support the pilot funding program for junior investigators by pairing junior investigators
with mentors in relevant areas of expertise and overseeing the scientific contributions of the junior investigators
through these pilot projects. The working groups will focus on key methodological issues relevant to optimizing
the implementation of STAND, including multivariate predictive modeling for improving triaging and adaptation
to level of care and risk detection, engaging students, health disparities and cultural competency, and integration
to increase the likelihood of adoption and sustainability. In partnership with our stakeholders and guided by
scientific experts in diversity issues in mental health, we have already adapted STAND to meet the cultural
diversity and social determinant needs of community college students in California, and will continue to make
these adaptations with Center expertize and stakeholder input. The Methods Core will also support
interdisciplinary collaborations, generating new research ideas that emerge from the Center activities, and will
assist with generating products for dissemination to the research and clinical communities (e.g., data-driven
algorithms for triaging and adapting level of care and for risk detection, innovative approaches to student uptake
and engagement and protocols for training clinicians and coaches). Finally, the Methods Core will serve as the
centralized hub for data management and infrastructure. All activities of the Methods Core will be guided by the
Acceleration Creation to Sustainment implementation framework that enables iterative evaluation and redesign
in accordance with a principle statement, to allow continuous to improvement to STAND over the five years of
the grant.